RESPIRATORY MUSCLE DURING SLEEP--EFFECTS OF ALCOHOL AND BENZODIAZEPINES

Evaluates the effects of commonly used amounts of alcohol and sleeping pills on respiratory EMG response to various stimuli. The response of healthy older adults (60+ yrs) will be compared with those of healthy young adults (30 yr or less). Alcohol, benzodiazepines, and placebo will be administered in a double blind fashion. Electromyograms (EMG) will be recorded from the genioglossus, scalene, diaphragm, and abdominal muscles.